Data Management and Biostatistics

CORE 2 – ABSTRACT
Core 2, the Data Management and Biostatistics Core, will serve the program by supporting all projects with
centralized data storage and management, analysis and sharing. The core will build and maintain a central
database that will securely manage project data and enable cross-project collaborations, perform biostatistical
and bioinformatics analyses, and create innovative solutions for sharing of data resources with the scientific
community. Core 2 will promote synergy in the program by providing all projects with ready access to consistent,
integrated data sets and data exploration tools; advanced, coordinated analytic services; and innovative,
cohesive data sharing solutions.